Protein modification and the aging phenotype of human skeletal muscle

Project Summary
Age-related reductions in muscle contractile performance are mediated by reductions in muscle size (atrophy)
and alterations in actin-myosin cross bridge function that are independent of size. Together, they contribute to
sarcopenia, the age-related loss of skeletal muscle mass and function. A hallmark of sarcopenia is the loss of
contractile power (= product of force and velocity) which, in turn, predicts physical dysfunction, and mobility
disability. Importantly, contractile power declines earlier in life and more precipitously than reductions in
contractile force or muscle size, thereby suggesting that power is subject to the influence of unique
mechanisms. During repeated contractions of high velocity, muscle fatigability is also increased with age, such
that older, healthy adults experience a much greater reduction in muscular power over the course of a
single bout of repeated voluntary contractions. In combination, these aspects of muscle aging leave older
adults at greater risk of falls and physical impairments during repetitious activities (stair climbing, walking etc.).
Somewhat paradoxically, muscle tension (force per unit cross sectional area) has been shown to increase
with age when contractile velocity is zero (isometric). Similarly, older adults are less fatigable during
isometric contractions. This constellation of poorly understood functional characteristics defines an Aging
Phenotype of skeletal muscle whose mechanisms may reveal important targets for intervention for improving
physical function in older adults with sarcopenia. We propose that alterations in cross-bridge level biology in
the aging sarcomere contribute to velocity-dependent contractile dysfunction and will perform experiments in
human skeletal muscle to test the hypothesis that the sarcomeric protein Myosin Binding Protein C (MyBP-C)
is central to this phenomenon.
MyBP-C is a regulatory protein located near the center of the sarcomere, known to modulate myocardial
contractility via phosphorylation-dependent interactions with the thin and thick filaments. While skeletal and
cardiac isoforms of MyBP-C are highly conserved and share structural and sequence homology, it is not clear
whether MyBP-C has similar phosphorylation-dependent influences on skeletal muscle contractility. Recent
pre-clinical studies suggest skeletal MyBP-C phosphorylation influences contractile force and velocity, and age
and fatiguing contractions alter phosphorylation differentially. Our studies in isolated human single muscle
fibers will translate pre-clinical evidence to humans and allow us to interrogate the influence of MyBP-C on age
and fatigue-related changes in skeletal muscle contractility. We will identify post translational modifications to
sarcomeric proteins with age and fatigue while screening for other candidates of interest within the human
muscle cell. These studies will reveal important information regarding the poorly understood Aging Phenotype
of Skeletal Muscle while establishing foundational data supporting the pursuit of molecular targets for
interventions with the goal of improving clinical outcomes in older adults.

Public health relevance
Project Narrative Age-related muscle atrophy and contractile dysfunction have been well described at the cellular level, but the molecular mechanisms that contribute to this dysfunction are poorly understood. Improved understanding of these mechanisms is critically important for the improvement of physical rehabilitation in older adults at risk for mobility impairment and physical disability. Our studies will pursue pre-clinical evidence that post translational modification of specific proteins in skeletal muscle lead to an “aging phenotype” in skeletal muscle that may unlock new strategies for improving physical function in older adults with physical frailty.